Blackfeet Community College Center for Community Medicine

for Career Enhancement 001- Student Career Enhancement Program
We believe that Native communities are best suited to carry out the research necessary to mitigate the chronic health diseases they experience. Our ultimate goal is to facilitate the Blackfeet Nation looking to its own tribal college to help address its health problems either by using existing college expertise or by adding to that expertise through collaborations. The Blackfeet and other Native peoples experience significant chronic health diseases, and, arguably, the best qualified individuals to address these disparities are Native researchers. However, there are precious few Native investigators with health research expertise and few sustainable health research centers within Native communities that are controlled by the community. With our current NARCH funding, we have been successful in developing research career interest in Blackfeet Community College (BFCC) students. Eight students were authors on two scientific publications, which opened educational and employment opportunities for them, and two students transferred into laboratory baccalaureate programs. Another student has transferred into medical school. Two of our students are employed at the Blackfeet IHS Hospital as laboratory technicians, and three went to Montana State University to conduct biofilm research. We also have 10 students developing middle school curriculum science educational experiences through a collaboration with MSU’s Science Education Partnership Award (SEPA), a program supporting educational activities encouraging pre-college students from diverse backgrounds, including those from groups underrepresented in the biomedical and behavioral sciences, to pursue further studies in STEM. Many of our students have presented their research to community members, including at our annual research conference. Thus, in this application, we propose a student career enhancement project, the Student Career Enhancement Program (SCEP), that will build on the success of the current NARCH student research development program. We believe this new program will, in the long term, enhance the capacity of Blackfeet Community College (BFCC) to develop a sustainable Center for Community Medicine (BFCC-CCM). The SCEP will focus on building further the human resources and infrastructure necessary to develop a sustainable research center by continuing to develop interest among students to pursue research careers, complete education resulting in an ability to become independent investigators and return to the BFCC-CCM as researchers and mentors.
[29 lines]

Public health relevance
for Capacity Building 002 – Community Engagement Core] The Community Engagement Core will contribute to the accomplishment of the mission of BCC-CCM by maintaining good relationships with the Blackfeet community and providing BFCC-CCM researchers expertise in community engagement research and in the development of evidence-based interventions. Modified Research Strategy for Capacity Building 002 - Community Engagement Core Significance The Blackfeet Reservation has a high incidence of chronic diseases such as diabetes, rheumatoid diseases, cancer, and mortality from infectious diseases. Yet, our community is suspicious of research because of the lack of past research improving health. However, we have found that when they themselves are included in the design, control, and performance of the research, they are much more willing to support research efforts and participate in projects. Developing and maintaining trust and good relationships between researchers and the community are critical for the BFCC-CCM, and doing so is the responsibility of the Community Engagement Core (CEC). This core will work with BFCC investigators to utilize a community engagement approach to their research and employ evidence-based interventions. This responsibility makes the CEC critical to the mission of BFCC-CCM to improve the health of the Blackfeet Nation and create a sustainable research center. Innovation The CEC is innovative in that it is a research core located at a tribal college. In addition, the core will be staffed and managed by Blackfeet community members who know firsthand the importance and significance of research employing a community engagement approach. Thus, the CEC is the vital and critical bridge between BFCC-CCM and the Blackfeet Nation. Furthermore, the CEC is innovative in that it will offer BFCC-CCM investigators expertise and guidance in navigating the Blackfeet Nation IRB (BNIRB). CEC staff will work with investigators to submit applications that meet the expectations of the BNIRB from the start. Our experience is that friction between the BNIRB and investigators can occur when investigators submit applications that are incomplete or poorly crafted with the expectation that the BNIRB essentially rewrite the application to meet its requirements. CEC staff, particularly the core director, are experienced in developing BNIRB protocols and can facilitate effective applications early in the research process. Given that the BNIRB is comprised of Blackfeet community members and represents the Blackfeet community’s interests, the CEC is again functioning as the core responsible for generating and maintaining good relationships between the BFCC-CCM and the Blackfeet Nation. Leadership The Community Engagement Core will be directed by Ms. Emily Salois, a longtime resident of the Blackfeet Reservation. Ms. Salois has a master’s degree in social work from the University of Washington. She has been the lead community research associate for over 14 years (recently retired) with Montana INBRE’s IDeA Community Engagement Core (CEC), which is a shared core between Montana INBRE (IDeA Network of Biomedical Research Excellence) and the Center for American Indian and Rural Health Equity (CAIRHE) funded by the National Institute of General Medical Science of the National Institutes of Health through their Institutional Development Award (IDeA). Ms. Salois has worked with numerous community advisory boards and project leaders conducting CBPR projects on the Flathead, Blackfeet, Fort Peck, and Fort Belknap Reservations in Montana. She has dozens of publications in community engagement research in Native communities. A significant portion of her work has been in her home reservation. Ms. Salois received her associate’s degree from BFCC many years ago and has continued to work closely with BFCC in subsequent years. She is an Elder of the Blackfeet community and is very knowledgeable of Blackfeet culture and traditions. Ms. Salois will be advised on core administration by Dr. Ann Bertagnolli, who has directed the MT IDeA Community Engagement Core over the past 14 years and has worked with Ms. Salois for over 17 years. Ms. Salois will dedicate 3 months of effort to this project and will be responsible for the administration of the CCEC and training of new CCEC staff, BFCC-CCM investigators, BFCC-CCM Community Advisory Board, and Blackfeet community members who wish to participate in the center’s research. Community Research Associates. The CEC will employ two full-time Community Research Associates (CRAs) from the Blackfeet community, who will work with BFCC-CCM investigators to ensure they adhere to CER principles and that their projects progress. They will help investigators recruit a community advisory board (CAB) specific to their project, attend CAB meetings, together with the CAB advise investigators on their research approach, help recruit study subjects, help analyze data, and aid in disseminating research results to the Blackfeet community. We have found that Blackfeet Elders have been very effective in advising us on health issues and concerns of the community. In some of the previous BFCC-CCM projects funded through our current NARCH program, Elders helped to deliver the intervention. These Elders are highly respected in our community, as are their wisdom, experience, and knowledge. Thus, we will employ Blackfeet Elders to advise the CEC as necessary, advise investigators as needed, and help to deliver interventions for investigators when it is advantageous to do so. Elders will be paid a fee for service and will be recruited by Ms. Salois, the CEC director, who will work with them directly. Approach Native Americans have always known that traditional and culturally grounded interventions can be effective treatments for many diseases. However, we realize that for these approaches to become recognized beyond our own communities, we must generate Western scientific data supporting what we know. These data complement and often confirm Indigenous scientific knowledge that has been held over many generations. However, presenting the effectiveness of culturally grounded interventions as evidence-based outcomes not only emphasizes the validity we know our traditional and culturally grounded interventions have, but also communicates them through a Western evidence-based perspective that is important in garnering support from organizations such as the Indian Health Service (IHS) and third-party payers. The proposed BFCC-CCM is innovative in its design to generate the data needed to make traditional and cultural medicine more broadly recognized in Western science. Specifically, the BFCC-CCM will develop collaborative research between independently funded investigators with expertise in Western science and Native investigators whose experience is grounded in Blackfeet traditions and culture. Through these collaborations, Western science and traditional Blackfeet knowledge and culture can combine to demonstrate effective, culturally respectful ways to understand and improve the health of the Blackfeet Nation. The purpose of the Community Engagement Core is to maintain good relationships between the BFCC-CCM and the Blackfeet community and to train BFCC-CCM investigators in the design and implementation of community engagement research principles, the development of evidence-based interventions, and best practices for disseminating their research findings to both the Blackfeet and scientific communities. To realize these overall goals of the core, we will accomplish the specific aims highlighted below. Aim 1. Develop and maintain strong relationships between the Blackfeet community and the BFCC- CCM. BFCC is a community college supported by the Blackfeet Tribal Business Council and, thus, the broader Blackfeet community. It is critical that the BFCC-CCM maintains an excellent relationship with the Blackfeet community, which has been very supportive. Because of this support, we have had no problem recruiting hundreds of community members to participate in studies where they donated blood samples and answered extensive survey questions. Many of the participants had never entered the college’s Math and Science building, South Wind Lodge, where these blood draws and surveys took place. Participants expressed their pride not only in the facility, which is a LEED-certified building constructed a few years ago, but also in the Blackfeet investigators and students who conducted the research on chronic health diseases and topics they found important and of concern to the tribe. The BFCC-CCM will continue to cultivate its relationship with the Blackfeet community through the following activities and strategies: Meet with the BFCC-CCM Community Advisory Board, together with the BFCC-CCM leadership, at least quarterly to keep abreast of the CEC’s progress in maintaining good relationships with the community. Trust in research can be lost quickly by a Native community, so it is critical to keep abreast of the state of the relationship between the Blackfeet community and BFCC-CCM to ensure that any problems that arise can be dealt with quickly. Involve the community directly in the research. This is a pillar of community engagement research, and the CEC will constantly work with BFCC-CCM investigators, through establishment of their CABs, to guarantee the involvement of the community directly and choosing research topics of interest to the community. Work with Pilot Research Project Program (PRPP) investigators to perform their research in a manner consistent with the mission of the BFCC-CCM and acceptable to the community. The CEC will work with investigators to develop appropriate research protocols, including surveys, and evidence-based interventions and treatments. The acceptability of the research is important in maintaining a good relationship with the community. Guide the PRPP investigators in the dissemination of their research results back to the community, which is critical to the success of their projects and keeping good relationships with the community. Guide new BFCC-CCM investigators in navigating the application process with the Blackfeet Nation IRB. CEC staff will work with investigators to submit applications that meet the expectations of the BNIRB from the start of their projects. Our experience is that friction between the BNIRB and investigators can occur when investigators submit applications that are incomplete or poorly crafted with the expectation that the BNIRB essentially rewrite the application to meet its requirements. Ms. Malaterre, as part of the CEC staff, and the core director are experienced in developing BNIRB protocols and can facilitate effective applications early in the research process. Given that the BNIRB is comprised of Blackfeet community members and represents the Blackfeet community’s interests, the CEC is again functioning as the core responsible for generating and maintaining good relationships between the BFCC-CCM and the Blackfeet Nation. Aim 2. Provide BFCC-CCM investigators with expertise in developing and implementing community engagement research methodology. A goal of the BFCC-CCM is to fund Blackfeet investigators to perform research that will generate preliminary data to inform the development of evidence-based interventions. The CEC will work with the PRPP investigators in all stages of their research to ensure that the principles of community engagement research are maintained throughout their projects. CEC staff will train investigators in good community engagement research principles and mentor them in ways to translate these principles into the development of their projects’ research design, implementation and dissemination. Training investigators in Community Engagement Research. All BFCC-CCM investigators and potential investigators are eligible to access CEC resources at any stage of their research from preparing proposals through disseminating research results. Using a methodological approach grounded in CBPR practices, the CEC will foster research led by the Blackfeet community. Core staff will highlight CBPR principles as they have been characterized in Western scientific literature but also present them through the Blackfeet worldview and ways of knowing and interacting with their community and all their relatives. Having facilitated research through both Western and Indigenous worldviews over many years, Ms. Salois, CEC director, is well-versed in how these worldviews both clash and have the potential to coexist effectively and will train her CRAs in how they differ as well as what they contribute to research. For example, included in CBPR principles in the Western scientific literature is the idea that community is a unit of identity and that research should build on both its strengths and resources (36). These principles emphasize collaborative approaches to research, promoting co-learning and capacity building among all participants and “integrating and achieving a balance between research and action for the mutual benefit of all partners” (36). Additional principles (especially those enumerated in publications by Barbara Israel), include the importance of emphasizing “local relevance of public health problems and ecological perspectives that recognize and attend to the multiple determinants of health and disease” (36). All CBPR research includes as one of its core principles the dissemination of research findings and knowledge gained to communities as well as the involvement of communities in the dissemination process. Dissemination and implementation practices also are well-represented in Western scientific literature and provide frameworks for how both can be achieved (35-40). However, many of these principles are evident, though practiced in traditional cultural ways, among our Blackfeet people. Our worldview is relational at its core and spiritually oriented. People, objects, and the environment are all connected, and our identity comes from this connectedness. Thus, CBPR principles have been a part of our traditional knowledge and ways of learning for many generations, though in a worldview that differs from a Western worldview. Where the Western worldview prioritizes quantitative data, evidence-based outcomes, objectivity, and linear thinking, Indigenous worldviews emphasize experience, observation, relationships, qualitative data, and a cyclical way of thinking. Quantitative analysis is only one aspect of this worldview and is not foundational in the same way it is in Western science. Both worldviews will coexist in the research conducted in the BFCC-CCM, but both must be recognized for the value they bring to research and the development of interventions designed to improve Blackfeet health. The CEC will facilitate researchers’ awareness of how this co-existence can happen. Throughout all center research, our traditional knowledge, culture, and traditions will be incorporated, playing an equitable role with Western science in developing research and interventions with the potential to improve the health of the Blackfeet Nation. Blackfeet individuals interested in community engaged research will contact Ms. Salois directly, and she will either advise that person or assign them to a Community Research Associate (CRA). All individuals who seek CEC help will be required to attend the training workshops provided by the CEC director and CRAs and encouraged to view online tutorials on community engaged research, such as the free online modules provided by the University of Minnesota’s Clinical and Translational Institute’s Services (under Community Engagement Tools & Resources). Additionally, they will have access to all the resources and expertise of the MT IDeA Community Engagement Core (described under the Leadership section above). The CEC will offer its training workshops twice a year, once just after the Pilot Research Project Program (PRPP) RFA is distributed and again just after the PRPP awards are announced. However, CEC staff will be available to guide researchers beyond scheduled workshops and work with them one-on-one as necessary or in small groups. Implementation of Community Engaged Research. CRAs that are assigned to PRPP-funded investigators will meet with them to discuss their application and determine whether the project requires its own CAB. If a CAB is required, the CRA will work with the investigator to recruit CAB members and will attend CAB meetings together with the investigator. The CAB will give advice to the investigator on research protocol design, endpoints to be collected, and analysis of data. The CRA will give the same advice as the CAB if no CAB is needed. Finally, the CAB or CRA will advise investigators on best practices for disseminating their research results. Aim 3. Provide BFCC-CCM investigators expertise in developing and implementing evidence-based interventions. The ultimate goal of the BFCC-CCM is to develop and implement interventions that will improve the health of the Blackfeet Nation. The CEC will work with the PRPP investigators in all stages of their research to develop and implement evidence-based interventions. CEC staff will train investigators in developing and implementing these interventions and mentor them to ensure that they adhere to community engagement research principles in the development of their projects’ research design and implementation. Training Investigators in design of evidence-based interventions. First, the CEC director and CRAs will offer workshops just after PRPP RFAs are distributed and again after PRPP awards are announced. These workshops will emphasize the role of the Blackfeet worldview and ways of knowing in developing interventions but also focus on evidence-based research that leads to interventions. Secondly, CEC Elders will offer presentations and discussion forums following workshops provided by the CEC staff. Elders’ presentations and discussions will be more conceptual, covering Blackfeet culture, ceremonies, and traditions. Implementation of interventions. If an investigator is administering an intervention, the CRA assigned to the investigator to advise on community engaged research, also will advise on the intervention. Investigators who plan interventions certainly will have developed community advisory boards. The CRA will help develop these CABs and will work with the investigator to gain the CAB’s advice on intervention design, administration, data analysis and dissemination of results. Some interventions will require participation by a CEC Elder. The CEC director, Ms. Salois, will recruit an Elder to advise and administer the intervention. In those cases, the CRA will coordinate the activities of the intervention and the participation of the Elder. The BFCC-CCM Community Engagement Core plays a critical role in bridging research methodologies that can result in measurable outcomes impacting the health of the Blackfeet Nation. CEC staff have a significant responsibility both in maintaining strong relationships with the Blackfeet community and in facilitating meaningful research informed by two worldviews that have not typically shared common ground (41-43). Indeed, CEC staff’s facilitation of CBPR projects is one major way they can enhance and maintain the center’s relationship with community members. We believe that in spite of their differences, both worldviews offer benefits and value to the research we hope to conduct through the BFCC-CCM proposed in this application. Our experience in our current NARCH program has shown us that Western and Indigenous science can work together to result in significant research outcomes, demonstrated in the studies conducted by our faculty and students through the Student Research Laboratory. These students, overseen by BFCC faculty, helped to design, modify, administer, and analyze surveys completed by over 300 community members. Their effectiveness in community engaged research has been widely recognized and praised by the Blackfeet community, as has their success in participant recruitment. Results of their work highlighted interventions and were published in mainstream scientific journals (33-35). These studies are indicative of the promise of BFCC-CCM research to impact Blackfeet health. Training provided through the CEC (see Figure 1) in community engagement research practices, including dissemination of results, is comprehensive and effectively prepares future Blackfeet researchers to achieve this same success. Figure 1. Timeline and Milestones Year 1 Year 2 Year 3 Year 4 Year 5 CCEC Director Hire/train 2 CRAs Develop workshops Invite Elder(s) Meet w/potential researchers Meet quarterly w/center CAB & leaders Provide 2 workshops Advise PLs on CAB members Work w/PLs in their research Assign CRAs to funded projects Advise PLs on BNIRB apps Advise PLs on interventions Advise PLs on dissemination Plan w/AC annual research meeting Enhance workshops as needed Invite Elder(s) Meet w/potential researchers Meet quarterly w/center CAB & leaders Provide 2 workshops Advise new PLs on their CABs Work w/PLs in their research Assign CRAs to funded projects Advise PLs on BNIRB apps Advise PLs on interventions Advise PLs on dissemination Plan w/AC annual research meeting Enhance workshops as needed Invite Elder(s) Meet w/potential researchers Meet quarterly w/center CAB & leaders Provide 2 workshops Advise new PLs on their CABs Work w/PLs in their research Assign CRAs to funded projects Advise PLs on BNIRB apps Advise PLs on interventions Advise PLs on dissemination Plan w/AC annual research meeting Enhance workshops as needed Invite Elder(s) Meet w/potential researchers Meet quarterly w/center CAB & leaders Provide 2 workshops Advise new PLs on their CABs Work w/PLs in their research Assign CRAs to funded projects Advise PLs on BNIRB apps Advise PLs on interventions Advise PLs on dissemination Plan w/AC annual research meeting Enhance workshops as needed Invite Elder(s) Meet w/potential researchers Meet quarterly w/center CAB & leaders Provide 2 workshops Advise new PLs on their CABs Work w/PLs in their research Assign CRAs to funded projects Advise PLs on BNIRB apps Advise PLs on interventions Advise PLs on dissemination Plan w/AC annual research meeting CCEC CRAs With Director: develop workshops Meet w/potential researchers Provide 2 workshops Advise PLs on CAB members Work w/ assigned PLs in their research Advise PLs on BNIRB apps, intervention, & dissemination Plan w/AC annual research meeting With Director: develop workshops Meet w/potential researchers Provide 2 workshops Advise PLs on CAB members Work w/ assigned PLs in their research Advise PLs on BNIRB apps, intervention, & dissemination Plan w/AC annual research meeting With Director: develop workshops Meet w/potential researchers Provide 2 workshops Advise PLs on CAB members Work w/ assigned PLs in their research Advise PLs on BNIRB apps, intervention, & dissemination Plan w/AC annual research meeting With Director: develop workshops Meet w/potential researchers Provide 2 workshops Advise PLs on CAB members Work w/ assigned PLs in their research Advise PLs on BNIRB apps, intervention, & dissemination Plan w/AC annual research meeting With Director: develop workshops Meet w/potential researchers Provide 2 workshops Advise PLs on CAB members Work w/ assigned PLs in their research Advise PLs on BNIRB apps, intervention, & dissemination Plan w/AC annual research meeting